Project 1

PROJECT SUMMARY/ABSTRACT
Mucormycosis, caused by Mucorales fungi, is a life-threatening infection that occurs in patients
immunocompromised by diabetic ketoacidosis, neutropenia, corticosteroid use, and/or increased serum iron.
Commonly initiated via inhalation of spores, clinical hallmarks of mucormycosis are the virtually uniform presence
of extensive angioinvasion with resultant vessel thrombosis and tissue necrosis. These features highlight the
importance of the ability of the fungus to invade alveolar epithelial cells (AECs) to initiate the infection. They also
emphasize the significance of penetrating the endothelium during the progression and dissemination of the
disease. Finally, the extensive tissue necrosis points to the presence of fungal toxins.
We determined that Mucorales initiate infection when the spore coating protein (CotH) invasins bind to integrins
α3β1 on AECs. This binding triggers the activation of AEC epidermal growth factor receptor (EGFR) to induce
invasion of germinated spores. We also discovered that germinated spores disseminate through the pericytes
and extracellular matrix to invade endothelial cells via CotH interacting with Glucose Regulated Protein 78 (GRP-
78). We also made the seminal discovery that Mucorales damage host cells by a cell-associated ricin-like toxin,
named mucoricin. Both CotH invasins and mucoricin are required for pathogenesis and antibodies targeting
either protein are protective in mice. More recently, we discovered that Mucorales also secrete another toxin that
belongs to the sphingolipid family, and is most operative during hypoxia and hematogenous dissemination.
Our goal is to gain insights into the mechanisms by which toxins dampens the host immune response and to
develop multiple immunotherapeutic strategies that will collectively nullify critical virulence factors of Mucorales
and enhance disease diagnostics. Thus, in Aim 1 we will determine the mechanism by which mucoricin prevents
neutrophil coordinated clustering (swarming) and cause death to this first-line innate host defense. We will also
assess the benefit of combining a protective anti-mucoricin monoclonal antibody (MAb) with antifungals and
other non-cellular FDA-approved immunomodulators (cytokines, immune checkpoint inhibitors, and
hematopoietic growth factors). In Aim 2 we will characterize the role and the mechanism of action of the
sphingolipid toxin (sphingotoxin) in mucormycosis pathogenesis by using genetic and biochemical blocking
strategies and conduct comparative in vitro and in vivo transcriptomic studies using isogenic strain pairs lacking
the ability to secrete the toxin. In Aim 3, we will examine the feasibility of developing a loop-mediated isotheral
amplification (LAMP) assay for rapid diagnostics of mucormycosis using unique targets of Mucorales including
rDNA, CotH, mucoricin, and other genes identified by the Genetic/Transcriptomic Core.
Overall, our well-integrated proposed aims will mechanistically define the contribution of toxins to mucormycosis
pathogenesis, and identify novel immunotherapeutic strategies and diagnostics that will be candidates for clinical
testing.